Defining the role of phenotypic heterogeneity in Clostridioides difficile fitness

SUMMARY ABSTRACT
Clostridioides difficile causes antibiotic-associated disease ranging from mild diarrhea to potentially
fatal pseudomembranous colitis and is one of the most common causes of nosocomial infections in the U.S. C.
difficile disease is largely mediated by the toxins TcdA and TcdB, which damage the intestinal epithelium and
elicit inflammation. How C. difficile adapts to the intestinal environment to elicit virulence factor production is
unclear. The expression of the genes encoding TcdA and TcdB is linked to expression of genes for flagellum
biosynthesis and motility through SigD, a sigma factor encoded in the flgB operon. Factors that affect
expression of the flgB operon therefore impact both motility and toxin production. Transcription of the flgB
operon is subject to complex regulation. The signaling molecule c-di-GMP inhibits transcription of flgB,
resulting in loss of flagella and reduced toxin production. In addition, a reversibly invertible ‘flg switch’
sequence upstream of flgB modulates expression and results in phase variation of flagella and toxins. This
phase variation occurs stochastically and enables the generation of a phenotypically heterogeneous population
consisting of flagellated, toxigenic bacteria and aflagellate, nontoxigenic bacteria and serves as a bet-hedging
strategy to ensure survival. We have shown that flagellum and toxin production is coupled during infection of
mice and preventing flg switch inversion alters infection outcomes. Recent work demonstrated that a c-di-GMP
hydrolase also undergoes phase variation and modulates flagellar motility. These findings link c-di-GMP
signaling and phase variation and point to a previously unknown strategy for coordinated modulation of
virulence factors and development of phenotypic heterogeneity. The goal of this project is to define the
interplay between the stochastic and regulatory mechanisms underlying the heterogeneous expression of
flagella and toxins. We propose to use molecular genetics, single-cell analyses, and an animal model of C.
difficile disease to address fundamental questions: Is phase variation of flagella and toxins regulated beyond
stochastic inversion of the flg switch? Do certain environments result in coordinated phase variation of flagella
and toxins with other factors? What is the impact of flagellum and toxin phase variation on C. difficile fitness
during infection? Completion of the proposed studies will provide much needed mechanistic information on
how C. difficile controls production of key virulence factors and the impact on C. difficile fitness in the intestinal
environment.

Public health relevance
Project Narrative The proposed research is relevant to the mission of the NIH because it will define how Clostridioides difficile, an important human intestinal pathogen, regulates the production of factors necessary for causing disease. The objective of the proposed research is to define the mechanisms underlying heterogeneous production of virulence factors in a C. difficile population and to determine how this heterogeneity impacts fitness of this pathogen during infection. Understanding how C. difficile regulates these virulence factors may reveal new strategies for diagnosis, prevention, or treatment of C. difficile infections.